Potential Biomarkers for Filovirus Vaccine Efficacy

This IAA supports the studies to assess the expression and biological activity among the twelve subtypes of IFN-alpha and three subtypes of IFN-Iambda with the goal of showing that expression patterns of IFNalpha and IFN-Iambda will serve as a rapid marker for protective vaccination against Ebola and other filovirus infections.